Integrative Structural Biology in DNA Replication and Damage Response

PROJECT SUMMARY
Faithful replication of DNA and response to encounters with aberrant DNA are essential to cell propagation and
survival. Our long-term goal is to understand the action of multi-protein DNA replication and damage response
machinery at eukaryotic replication forks. Our strategy is to elucidate the structural mechanisms using an
integrative structural biology approach, coupled to biochemical/biophysical characterization and collaborations
to define functional implications. This proposal focuses on critical unsolved questions about the initiation of
daughter strand synthesis in replication, and the stalling and remodeling of replication forks upon encountering
aberrant DNA. In DNA replication, the processive polymerases δ and ε require a short primer strand on the
template to function, which is generated by DNA polymerase a-primase (pol-prim). Although 3D structures have
been determined for all components of pol-prim and even the intact heterotetramer, these have provided only
limited mechanistic insights because structures of the full-length protein with relevant substrates and essential
co-factors are lacking. To address this critical gap in knowledge, we propose to determine the relevant structures
using Cryo-EM. We also propose to continue working on characterizing the structure, biochemical properties
and functional roles of 4Fe-4S clusters in pol-prim. We will test and refine our hypotheses about the role of: (i)
the primase 4Fe-4S cluster redox in modulating DNA binding activity; (ii) the role of the cluster in pol α in driving
the transition from RNA synthesis by primase to DNA synthesis by pol α. Together, these studies will solve the
fundamental questions about how pol-prim counts the length of the primer at each step and how the substrate
hand-offs occur from primase to pol α and then from pol α to pols δ or ε. Our second project addresses two
critical gaps in knowledge about replication fork encounters with aberrant DNA. RPA and Rad51 are two highly
abundant ssDNA binding proteins that have critical roles in the stalling, reversal and stabilization of stalled forks.
RPA-coated ssDNA is the key initiating signal for multiple damage response pathways and plays several
additional roles, including recruiting and directing the fork reversal activity of the ATP motor protein SMARCAL1.
We propose to elucidate the mechanisms that drive this important aspect of fork remodeling by determining the
structure of the RPA and SMARCAL1 on a model fork substrate complex using Cyro-EM. Rad51 plays an
essential role in the stabilization of stalled replication forks. Collaborative studies with David Cortez led to the
discovery and characterization of RADX, a new DNA damage response protein involved in regulating the activity
of Rad51 at stalled forks. We recently discovered RADX also interacts physically with RPA, suggesting there is
a RPA-RADX-Rad51 network operating at stalled forks. We propose combined structural, biophysical and
functional analyses of RADX and its interactions with DNA, Rad51 and RPA to clarify the roles of RADX at stalled
replication forks. Together, our two projects will greatly enhance understanding of how DNA is processed at
eukaryotic replication forks and genomes are maintained and propagated.

Public health relevance
Narrative Faithful replication and maintenance of our genomes, which is vital to our survival, requires the action of complex multi-protein machinery that replicates our DNA and responds respond to aberrations in DNA that arise as a by-product of exposure to environmental toxins, sunlight, and even molecules produced naturally in cells. Defects in these protein machines lead to mutation and ultimately cancer and other diseases associated with genomic instabilities. Investigating the three-dimensional structure of the protein components of DNA replication and damage response machines and their interactions with each other and with the DNA will reveal intricate details of how replication and damage response occurs, what is defective in disease-associated mutant proteins, and open up new avenues for development of targeted therapies for patients suffering from maladies such as cancer that arise as a result of genomic instability.